Assessing the role of Type I Interferon (IFN-I) in Periodontal Disease

Project Summary
Periodontitis, which results in irreversible damage in hard and soft tooth-supporting tissues, affects 42% US
adults. This extremely prevalent inflammatory oral disease is also tightly associated with systemic diseases
such as diabetes. Clinical studies have shown that periodontitis contains mixed disease phenotypes. For
example, the disease progression pattern in about 20% of periodontitis patients is clearly distinct from that of
the majority in a population. Recently, we used a data-driven approach to create a periodontal profile
classification (PPC)-Staging system by integrating periodontal measurements and indices from a closely
followed up community cohort. After validation, we demonstrated that this new PPC-Staging tool has drastically
improved clinical associations with several systemic diseases including diabetes, stroke, and coronary heart
disease due to the improved homogeneity of each PPC-Stage (I to VII). Through a proteomic biomarker
analysis in the gingival crevicular fluid of a patient pool from the cohort, we found that the expression pattern of
the interferon-β (IFN-β) cytokine, a classical member of type I interferon (IFN-I), in PPC-Stages mimics that of
interleukin-1 receptor antagonist (IL-1RA), a well-described classical anti-inflammatory cytokine. This novel
finding prompted us to evaluate the role of IFN-I in periodontitis. Using a mouse periodontitis model, we found
that IFN-I plays a protective role in alveolar bone loss. We further found that such a protective role of IFN-I is
associated with a dampening of an interleukin (IL)-17-neutropphil axis, while the transcription of Il27 in local
gingiva was upregulated. The role of IL-27 in an integral IFN-I pathway has yet remained to be elucidated in
periodontitis. We further showed that IFN-β signaling suppressed the lipopolysaccharide-induced
proinflammatory cytokine production in and potently inhibited osteoclast differentiation from bone marrow-
derived monocytes. We therefore hypothesize that an integral IFN-I response in monocytic lineage plays a
protective role in periodontitis by deactivating an IL-17-neurophil axis through an IL-27 pathway. We seek to
gain insight into the mechanism of IFN-I in modulating innate and adaptive immune responses in periodontal
disease. We propose to test this central hypothesis by the following approaches: 1) we will first define the role
of Type I IFN- IL-27 pathway in IL-17-neutrophil axis using the animal periodontitis model; 2) we will then
assess the specific role of IFN-I signaling in myeloid lineage that contains monocytic /osteoclast precursor cells
in the periodontitis model; 3) we will also evaluate the effect of a locally delivered novel nanoparticle-mediated
sustained release of IFN-β/IFN-I stimulator in the periodontitis model. Our goal of this project is to advance the
understanding of INF-I, a clinically relevant yet under-investigated molecule, in periodontal disease, and to
leverage IFN-β or IFN-I-centered inflammatory networks as biomarkers to further refine the clinical periodontal
disease classification. In addition, this research proposal will provide evidence to target IFN-Is as an adjunctive
therapeutic measure in a subset of patients to improve precision periodontal health.

Public health relevance
Project Narrative Periodontitis is one of the most prevalent inflammatory diseases in humans and harbors heterogeneous disease phenotypes. A biomarker analysis in stages of a new periodontal profile classification, which improved the homogeneity within each disease stage, identified that Type I interferon played a novel regulatory role in periodontitis. This translational research program will delineate the mechanism of Type I interferon in dampening excess innate and adaptive immune response involved in periodontitis and evaluate the effect of a nanoparticle-mediated sustained delivery system that activates and releases Type I IFN locally in periodontitis.